Investigator Development Core

SUMMARY/ABSTRACT - INVESTIGATOR DEVELOPMENT CORE
The RCMI-Center for Collaborative Research in Health Disparities (RCMI-CCRHD) at the University of Puerto
Rico Medical Sciences Campus proposes an Investigator Development Core (IDC) for its budgetary cycle 2017-
2022. The RCMI-CCRHD will coordinate a pilot-project program (PPP) to nurture the growth of promising junior
faculty within the UPR-MSC by soliciting and reviewing grants, and awarding funds to innovative proposals that
will lead to competitive independent funding. The overall goals of the IDC are three-fold: 1) to mentor early career
investigators as they transition to independent funding; 2) to fund innovative basic, behavioral and/or clinical pilot
projects focusing on health disparities and/or minority health; 3) to match RCMI faculty with outside
collaborators/mentors in order to strengthen collaborative networks. At the end of the proposed cycle, it is
expected that 6-8 Early Stage Investigators (ESI), working on basic biomedical, behavioral and/or health
services/clinical research, will have been funded, mentored, and well on their way to independent funding
relevant to minority health and health disparities. We plan to accomplish this goal through the following Specific
Aims: Grantees will receive a two-year grant of $40-50,000 per year in order to sustain studies for a sufficient
period of time to compete successfully for outside funding. Mentoring activities will include bimonthly meetings
to review progress, developing personalized short- and long-term career development plans, rehearsal of
scientific presentations, discussion of topics relevant to successful transition to running their own labs; and CSR-
style mock study-sections. Tracking and evaluation mechanisms will be established to measure scientific
progress and ensure that the goals of the program are met, including increasing the number of publications,
generating preliminary data, and increasing grant applications and awards (including R-type and K awards).
Outcome metrics will be used to refine or refocus the solicitation, review, selection, and funding of applications
made to the PPP. Staff from the Administrative Core will support and monitor full compliance with local and
federal regulatory requirements. The IDC will be directed by Dr. Gregory J. Quirk, a retired senior neuroscientist
at UPR-RCM, and Dr. Luis Montaner, a senior scientist and Vice President for Scientific Operations at The Wistar
Institute in PA. Both directors have extensive mentoring experience, which has been documented in recent
publications. The directors will be assisted by the scientific mentors to include added scientific expertise as
determined by mentee needs inclusive of representation of the basic, behavioral and health services/clinical
areas. The IDC will coordinate closely with other NIH-supported programs at the UPR-MSC to share mentoring
activities and resources and avoid support overlap.

Public health relevance
Project Narrative – Investigator Development Core As per RFA MD-22-002 instructions, this section is only required on the Overall Section.